Allergen-specific lung-resident Tregs in asthma: Targetable suppressors of resident memory Th2 cells

Asthma is one of the most common chronic diseases and it is still on the rise with a prevalence of ~8% of the
U.S. population and an estimated cost of $82 billion/year. New therapeutic approaches are needed that offer the
potential for a long-lasting cure. Allergic asthma is the most common endotype and is thought to be driven in
large part by a type 2 airway immune response to inhaled allergens. Foxp3+ regulatory T cells (Tregs) are potent
suppressors of immune responses and are an attractive target to treat allergic asthma. The CD4+ T helper type
2 (Th2)-mediated response to environmental allergens that drives allergic asthma is thought to be due to an
imbalance between allergen-specific effector and regulatory responses. Recent studies by us and others have
demonstrated that resident memory (Trm) Th2 cells that reside in the lung are key effector cells that drive many
of the features of allergic asthma. Th2-Trm cells proliferate near airways following allergen challenge and are
responsible for inducing mucus metaplasia, airway hyperresponsiveness, and airway eosinophil activation. While
memory T cells were believed to continually re-circulate within the host, it has recently become clear that Trm
remain anatomically positioned to initiate antigen-specific immune responses at barrier surfaces. In preliminary
studies, we have now found that allergen-specific Tregs also reside in the lung following aeroallergen
sensitization and are the key cell that suppresses the Th2-Trm response. This has led us to the central
hypothesis of this proposal that resident (r) Treg suppression of Th2-Trm is key to regulating the allergic asthma
phenotype. Th2-Trm exhibit a distinct transcriptional program that includes the upregulation of the chemokine
receptors CCR8 and CXCR6. In preliminary studies, we have found rTregs in the lung also upregulate CCR8
and CXCR6 during a type 2 response. This has led us to hypothesize that the CCR8 and CXCR6 chemokine
systems play roles in the tissue residency programs of Tregs and their ability to be juxtaposed to Th2-Trm around
the airways. The central hypothesis of this proposal will also be explored in humans with allergic asthma. Our
group has investigated the response to bronchoscopic segmental allergen challenge in humans with allergic
asthma (AA) and allergic non-asthmatic controls (ANA). We found increased airway type 2 cytokine production,
total mucin, and mucin MUC5AC in response to allergen in AA compared to ANA subjects. These findings
suggest that differences in the activation of Th2-Trm within the airways may be critical for allergen-sensitized
individuals to develop the asthma phenotype. We will test the hypothesis that differences in relative frequency,
phenotype and/or TCR specificities of rTregs in the lung underly the differences in the response to aeroallergen
in ANA and AA subjects. Specifically, we propose to: (1) Further define the role of lung rTregs in suppressing
Th2-Trm; (2) Determine the role of the CCR8 and CXCR6 chemokine systems in the tissue residency program
positioning and function of rTregs in the allergic lung; and (3) Extend these studies to humans by comparing the
numbers, phenotype and TCR specificities of rTregs in AA and ANA subjects.

Public health relevance
Foxp3+ regulatory T cells (Tregs) are potent suppressors of inflammation, including allergic inflammation that underlies the most common type of asthma. We have found that allergen-specific Tregs that persist in the lung are critical for suppressing the recall response to allergen but their numbers appear to wane over time. The goal of this project therefore is to understand the mechanisms of resident Treg cell persistence and function in the allergic lung in order to enhance the durability and function of resident Treg as a new treatment strategy for asthma.